TRPM8 in eye health and disease

Project Summary
Dry eye disease (DED) is a complex, multifactorial disease of the ocular surface characterized by a loss of tear
film homeostasis, with symptoms including ocular discomfort and visual disturbance. DED is one of the major
reasons for visits to optometry and ophthalmology clinics in U.S., with a higher apparent incidence and
prevalence in females and the elderly. With its negative impact on quality of life, DED is a major public health
concern. Despite the gravity of DED, current treatments are limited. This strongly suggests that new targets
with novel mechanisms of action are needed. Recent studies have uncovered the role of ocular sensory
neurons in ocular physiology and the etiology of DED, especially highlighting the role of the cold and
menthol receptor, TRPM8, in ocular pain as well as basal tear flow and hydration of the ocular surface. TRPM8
is a valid target for the treatment of DED, but the complex conformational landscape of TRPM8 has hampered
drug development. Our primary objectives are to gain a comprehensive understanding of the mechanism by
which TRPM8 is gated by ligands and to design and develop novel TRPM8-modulating compounds using
structural biology, chemical biology, medicinal chemistry, in vitro and ex vivo electrophysiology, imaging, and
animal model studies. Taken together, successful completion of this work will provide the framework for
TRPM8-targeted therapeutic development as well as reveal the molecular basis for ligand gating of TRPM8 –
with far-reaching implications in treating ocular disorders.

Public health relevance
Project Relevance Dry eye disease, ocular pain and ocular discomfort present significant challenges to our quality of life. There has been recent interest in therapeutics directly targeting the activity of ocular cold sensory neurons, due to their key involvement in eye physiology, dry eye disease and ocular discomfort. Our proposal aims to dissect the function and activation mechanisms of the cold and menthol receptor TRPM8, a critical thermosensitive component of ocular cold sensory neurons, which will set the stage for the development of novel drugs to combat dry eye disease and ocular pain.